CTSA Predoctoral T32 at the Ohio State University

The goal of this new Ohio State University (OSU) Center for Clinical and Translational Science (CCTS)
predoctoral training program is to leverage our large, collaborative, and multidisciplinary research environment
to increase the reach of CTS education and training across the OSU campus and to recruit and develop a
diverse cohort of trainees to become the next generation of clinical and translational scientist leaders. This
new program, built upon the foundation of 14 years of experience with the OSU CCTS TL1 program, aims to
provide trainees with knowledge, skills and abilities that will expand the scope of their current and future
research and prepare them to confidently communicate with diverse stakeholders and lead multidisciplinary
research teams to drive biomedical and clinical innovations. We aim to foster a learning environment
grounded in inclusive and culturally competent mentorship through mentorship training, monitoring and
constructive feedback. Post candidacy trainees are selected from a wide range of graduate programs in nine
colleges including Health Sciences Colleges (Medicine, Optometry, Public Health, Pharmacy, Nursing,
Dentistry, Veterinary Medicine), Engineering, Arts & Sciences, and three interdisciplinary graduate programs
(Biochemistry, Molecular, Cellular & Developmental Biology, Neuroscience). Trainees enroll in 2 required
courses that cover core concepts and include team based projects in CTS that emphasize research design and
methodologies that are rigorous, ethical, inclusive and intentional to achieve health equity. Trainees are
required to fulfill requirements of a Graduate Interdisciplinary Specialization in Biomedical Clinical Translational
Science (GISBCTS) selecting from coursework in 4 tracks (Research Methods; Statistics, Data Analysis and
Bioinformatics; Community and Communications, and Leadership/Team Science). Leadership and team
science skill development and resiliency training at this pre-doctoral stage is expected to favorably impact the
career trajectories of our trainees, increase retention of CTS investigators from all backgrounds and ultimately
enhance the breadth and impact of CTS for individuals and communities. Trainees attend Lunch & Learn
monthly seminars on a variety of research and career development topics facilitated by diverse faculty and
staff across colleges. Trainees select CCTS “Tools of the Trade” in-depth workshops that focus on research
topics like grant writing, community engagement, clinical trials management, and technology
commercialization. Collaboration with the CCTS workforce development team, community engagement team
and the K12 program permits cross-fertilization to enhance training across a spectrum of CTS researchers,
expansion of trainee networks, opportunities for peer mentoring and coordinated program evaluation of
learners at various career stages. The CCTS T32 Career Development Dinner Series includes informal
discussion with alumni and invited guests to highlight diverse research career paths and expand networking
opportunities. Trainees are supported for two years of training. Six training slots per year are requested.

Public health relevance
Project Narrative Research today provides hope and the foundation for new treatments and cures for tomorrow. Specialized education and training in clinical and translational sciences is needed to develop investigators capable of bridging the gap between the lab, the clinic, and disciplinary boundaries and to accelerate the delivery of innovations to all communities. The goal of this new Ohio State University Center for Clinical and Translational Science predoctoral T32 training program is to leverage the large, collaborative and multidisciplinary research environment of Ohio State to recruit, train and mentor a diverse cohort of trainees from a wide variety of graduate programs and colleges to become the next generation of clinical and translational science leaders who will lead high impact research that is rigorous, inclusive, ethical and intentional to achieve health equity.